FY21 CONSOLIDATED FACILITIES TASK ORDER A

The purpose of this project is to complete the high priority exterior repairs to the Building 578 exterior walls, doors and windows to seal all exterior leaks. Reference Drawing Set 578-03 for additional details